In pursuit of a one-stop shop: a hybrid type 1 effectiveness-implementation trial of comprehensive tele-harm reduction for people who inject drugs

ABSTRACT
People who inject drugs (PWID) remain a high priority population under the Ending the HIV Epidemic: Plan for
America (EHE) with 11% of new HIV infections attributable to injection drug use (IDU). IDU has led to multiple
recent outbreaks of HIV in the US, driven primarily by the ongoing opioid and stimulant crises, creating an
obstacle in meeting EHE goals of a 90% reduction in incident HIV infections by 2030 through the 4 pillars –
diagnose, treat, prevent, and respond. EHE has identified evidence-based interventions within these pillars,
including rapid HIV testing, antiretrovirals, comprehensive syringe services programs (SSPs), and PrEP that
need to be implemented, scaled, and sustained within communities most affected by HIV. To maximize and
extend the effectiveness of these interventions among PWID, differentiated, simplified, integrated, and
comprehensive healthcare models need to be developed, tested, and deployed where they are in comfortable,
destigmatizing environments that simultaneously address a key driver of HIV—substance use disorder (SUD).
In addition to HIV, PWID continue to be impacted by a myriad of harmful health conditions such as hepatitis C
virus (HCV), overdose, bacterial infections and sexually transmitted infections (STIs) due to structural, economic,
social, and policy constraints. PWID often experience discrimination, stigma, and considerable social
disadvantage, leading to almost universal poorer health outcomes than comparable populations who do not
inject drugs. The need for innovative, efficacious, scalable, and community-driven models of healthcare in
destigmatizing settings for PWID is crucial. Our team has led the development and testing of Tele-Harm
Reduction (THR): a telehealth-based, multicomponent, adaptive care model for PWID living with HIV. Building
on this work, we now seek to rapidly adapt and test Comprehensive-THR (C-THR) for comprehensive HIV
prevention services delivered via an SSP. We propose a hybrid type I effectiveness-implementation randomized
controlled trial (n=350) to evaluate the efficacy of the C-THR model vs. offsite referral and peer navigation for
engagement in HIV prevention (i.e., PrEP or medications for OUD). PWID will be recruited from an academic
medical center-based syringe services program (SSP) in Miami, FL (IDEA Miami) from both fixed and mobile
SSP modalities. There are three overall aims of the proposed study: (1) to determine if the C-THR model
increases engagement in HIV prevention compared to offsite referral and peer navigation, (2) to examine the
long-term clinical and cost-effectiveness of the C-THR model, and (3) to assess the implementation and
scalability of the C-THR model in diverse SSP settings. The co-primary outcome is tenofovir on dried blood spot
or buprenorphine on urine drug screen across follow-up at 3,6,9 and 12 months. Secondary outcomes will include
engagement in HIV/HCV/STI testing and sustained virologic response (SVR, cure) for HCV. The cost-
effectiveness analysis, long-term modeling, and mixed-methods implementation and scalability evaluation will
provide compelling data on the sustainability and possible impact of C-THR on comprehensive HIV prevention
delivered via SSPs in the COVID era and beyond.

Public health relevance
PROJECT NARRATIVE Comprehensive-Tele-Harm Reduction (C-THR) seeks to engage people who inject drugs (PWID) into comprehensive HIV prevention services by deconstructing the traditional healthcare system and leveraging syringe services programs as trusted venues to deliver telehealth-enhanced access to PrEP, medications for opioid use disorder (MOUD), hepatitis C (HCV) cure, and treatment for bacterial and sexually transmitted infections. We urgently need a strong evidence base to prove that Comprehensive-Tele-Harm Reduction can help us prevent HIV and save lives. We seek to set the foundation to build, implement, and scale-up a new standard of care for comprehensive HIV prevention and treatment in PWID.